Coding in Auditory Neurons: Effects of Amino Acids

DESCRIPTION (provided by applicant): Age-related hearing loss is a complex disorder affecting 30% of the US population aged 65 to 74 years, and 50% of the population over 75 years of age and older. Psychoacoustic studies in young and elderly subjects with similar thresholds show age-related decrements in temporal processing and speech understanding in noise. This suggests that seniors have difficulty attending to and comprehending speech in a public setting leading to a tendency to withdraw from society. The proposed studies are based on the underlying hypothesis which suggests that age-related hearing loss is, in part, a maladaptive plastic response to a slow progressive deafferentation at the auditory periphery. In many species, sound exposure, chemical or physical peripheral trauma alters physiologic responses and markers of adult inhibitory neurotransmission at multiple levels of the auditory pathway. Subcortical temporal coding studies suggest that inhibitory circuits: Allow neural responses to accurately follow the envelope/temporal fine structure of complex acoustic signals; Are involved in gain control; Are likely to provide the adaptive substrate for novelty detection (Yu et al., 2009). Studies completed during the previous grant period have shown that inhibitory neurotransmitters are critically involved in preserving temporal and spectral fidelity of coded complex acoustic signals as these signals ascend the auditory pathway. These studies found significant age-related changes in GABA- and glycinergic inhibitory pharmacology and physiology in the dorsal cochlear nucleus and primary auditory cortex. Proposal studies will examine the nature of GABAA receptors (GABAARs) at the level of the medial geniculate body (MGB) in the context of aging. The auditory thalamic nucleus receives lemniscal and extralemniscal ascending inputs as well as reticular, limbic and descending inputs from auditory and nonauditory cortices. Proposed studies seek to characterize the unique makeup of GABAAR in MGB and their functional involvement in attention/novelty detection and temporal processing. Proposed studies will examine age-related changes in the role of the inhibitory neurotransmitter GABA in the MGB. Preliminary iontophoretic, receptor binding and measures of GABAA subunit protein suggest an important role for one specific GABAA receptor subtype which is highly concentrated in young adult MGB. These extrasynaptic 14d subunit containing GABAA receptors show a profound reduction in aged animals. Specific studies will: 1) Determine age-related changes in the subunit makeup and pharmacology of GABAA receptor constructs in the MGB. 2) Determine the role of GABAA receptors in shaping responses to novel and temporally modulated stimuli in young and aged rat MGB neurons using iontophoretic techniques. 3) Determine age-related changes in response to temporally complex and novel stimuli in MGB neurons in unanesthetized rats. Collectively, these studies will begin to characterize the impact of aging on the function of inhibitory GABA circuits in the MGB and may provide a basis for development of selective agents which could potentially ameliorate certain kinds of age-related hearing loss.

Public health relevance
PUBLIC HEALTH RELEVANCE: Age-related hearing loss is arguably the second or third major malady of industrialized people, affecting 30% of the US population aged 65 to 74 and 50% of the population over 75 years of age and older. Older individuals have more difficulty understanding speech, especially in noise than younger adults. These threshold changes are at least in part, independent of inner ear hair cell loss. Previous studies supported by this grant strongly suggest that, the loss of certain inhibitory neurochemicals in the brain may be responsible for the observed age-related impairments in speech understanding. Preliminary studies suggest that one important auditory brain area, medial geniculate body, displays a profound age-related loss of one kind of inhibitory receptor. Proposed neurochemical studies will attempt to characterize the pharmacologic properties of this inhibitory receptor in young and aged animals. Electrophysiology will attempt to determine the impact of aging on the ability of brain cells in this area to process acoustic information in an unanesthetized rat model of aging. It is hoped that these studies could eventually result in the development of selective new drugs to improve speech understanding in a subset of elderly individuals. Project Narrative Age-related hearing loss is arguably the second or third major malady of industrialized people, affecting 30% of the US population aged 65 to 74 and 50% of the population over 75 years of age and older. Older individuals have more difficulty understanding speech, especially in noise than younger adults. These threshold changes are at least in part, independent of inner ear hair cell loss. Previous studies supported by this grant strongly suggest that, the loss of certain inhibitory neurochemicals in the brain may be responsible for the observed age-related impairments in speech understanding. Preliminary studies suggest that one important auditory brain area, medial geniculate body, displays a profound age-related loss of one kind of inhibitory receptor. Proposed neurochemical studies will attempt to characterize the pharmacologic properties of this inhibitory receptor in young and aged animals. Electrophysiology will attempt to determine the impact of aging on the ability of brain cells in this area to process acoustic information in an unanesthetized rat model of aging. It is hoped that these studies could eventually result in the development of selective new drugs to improve speech understanding in a subset of elderly individuals. __SpecificAimsTextDelimiter__ 2. Specific Aims Molecular, neurochemical and electrophysiologic approaches will be used in a continuation of studies designed to address the impact of aging on inhibitory amino acid neurotransmitter function within the central auditory system. Reduced input into sensory brain structures has a profound effect on normal adult inhibitory neurotransmission which is evident at multiple levels of the central auditory pathway (Syka, 2002). The elderly have significant difficulties with temporal processing and auditory attention tasks, especially in a cluttered acoustic environment. When hearing loss is matched to young-adult controls, they show age-related decrements in temporal tasks (see Section 3). Damping normally provided by inhibitory circuits enables neural responses to follow the envelope/temporal fine structure of complex acoustic signals and may be negatively impacted by aging. Age-related loss of inhibition, at different levels of the auditory neuraxis, has been shown to decrease gain control, increase jitter (temporal uncertainty) and decrease coding fidelity in the temporal and spectral domains (Table 1). Inhibitory GABAergic inputs from the thalamic reticular nucleus (TRN) appear to mediate the ability to detect novel responses in portions of the medial geniculate body (MGB) (Yu et al., 2009). An age-related loss in the ability to detect novel stimuli has been described in humans but has not been examined in an animal model, and may be linked to the loss of GABAergic inhibition (Alain & Woods, 1999; Yu et al., 2009). Preliminary studies suggest that one GABAA receptor (GABAAR) construct, the extrasynaptic a4d, is highly concentrated in MGB and undergoes a dramatic age-related decline. This age-related change is suggestive of a profound loss of tonic inhibition in aged animals. Aims of the present study seek to: 1) characterize the makeup and the pharmacologic properties of MGB GABAA receptors (SA1&2); and 2) characterize age- related changes in the functional properties of MGB neurons (SA2&3). If we can define age-related functional and receptor changes that occur in MGB and identify a unique receptor construct present in aged animals, then selective drug therapy could be developed to ameliorate certain kinds of age- related hearing loss (SA1-3). Studies of MGB in a rat model of aging will: 1. Determine age-related changes in the subunit makeup and pharmacology of the GABAA receptor constructs in the MGB. Hypothesis: Aging will specifically alter the subunit composition and distribution of GABAARs in the MGB. Preliminary in situ hybridization, immunocytochemical and quantitative receptor binding autoradiography suggest a dramatic age-related change in the number and pharmacology of GABAA constructs in MGB. Proposed studies will utilize: A) Quantitative immunocytochemistry and Western blots to determine GABAAR subunit protein levels in MGB; and B) Quantitative receptor binding autoradiography to assess age-related changes in the number and pharmacology of GABAARs in MGB. Binding studies will use subunit selective compounds, such as gaboxadol, RO15-4513, and t- butylbicycloorthobenzoate (TBOB). 2. Determine the role of GABAA receptors in shaping responses to sinusoidally amplitude modulated (SAM), and stimulus specific adaptation (SSA)/oddball stimuli in young and aged rat MGB neurons. Hypotheses: 1) Gaboxadol will inhibit neurons in young but not aged MGB. Preliminary studies found that the GABAA extrasynaptic agent, gaboxadol inhibited responses when applied onto young adult neurons but was ineffective at aged synapses. 2) GABAAR blockade and aging will decrease SSA/oddball selectivity and alter SAM coding. Preliminary studies show altered SAM coding in MGB neurons with GABAAR blockade. Yu et al. (2009) recently demonstrated dependence of the MGB stimulus specific adaptation (SSA) response on GABAergic input. Electrode location will be mapped to the subnuclei of MGB (Caspary et al., 1987, 2002). 3. Determine age-related changes in temporal coding and the ability to identify novel/oddball stimuli of MGB neurons in unanesthetized rats. Hypothesis: SSA/oddball selectivity and temporal processing will be impaired in aged rat MGB. Multichannel implanted silicon probes in MGB will be used to record sorted single units from young and aged unanesthetized FBN rats. Stimuli presented in a free-field sound attenuating chamber will include: SAM tones and tones of different frequency presented in an SSA/oddball paradigm. RF lesions at each node will allow location to be mapped to the subnuclei of MGB (Brozoski et al., 2006).